Indians into Medicine: Native Educator University Research Opportunity in Neuroscience (INMED: NEUROscience)

Project Summary/Abstract
American Indians are greatly underrepresented in medicine and biomedical career fields, corresponding to a
disproportionately low health status. Extensive research in K-12 STEM education confirms that student interest
in science starts at an early age, and needs to be continually fostered throughout the middle and secondary
school to attract students to science majors. An authentic research experience in a neuroscience laboratory
has the capability to increase a teacher's capacity to create engaging, and meaningful learning environments
that excite, support, and instill confidence in American Indian students, in an effort to help them overcome
some of the obstacles they face on the path to entering science fields and becoming STEM professionals. The
Indians Into Medicine: Native Educator University Research Opportunity in Neuroscience (INMED:
NEUROscience) is a comprehensive professional development program that is a collaborative effort drawing
on the strengths of neuroscience researchers, education faculty, and American Indian support professionals, to
provide a holistic approach that is both science-driven and culturally sensitive. INMED: NEUROscience brings
teachers in American Indian tribal middle and high schools together to: (1) conduct research in neuroscience
laboratories to gain a deeper understanding of the process of science; (2) connect with each other for peer
support, and with biomedical education faculty for pedagogical support; and (3) draw on the experience and
resources of American Indian support professionals for social and cultural support. Together, these
components help teachers identify ways to effectively translate laboratory research into inquiry-based,
engaging learning opportunities for students. The INMED: NEUROscience Research Education Program Plan
revolves around a general theme of integrating the process of science knowledge and STEM learning concepts
through an eight-week summer research experience in neuroscience. The research projects will expose
teachers to the real-world use of the “scientific method” and research techniques, which will be followed-up by
targeted science pedagogy training to create transformative learning activities. Teachers are provided with
science content in an explicit manner in the lab, while growing their pedagogical knowledge and skills as they
create, implement, and reflect on their lesson plans in the classroom. The evaluation plan incorporates many
aspects that examine both explicit and embedded content delivery methods. Data collection includes
questionnaires, teaching demonstrations, direct observations, lesson plan evaluation, and informal
discussions. Overall, the program will promote teachers' effective implementation of the process of science into
their classrooms, leading to inquiry-based science courses, which foster academic achievement and afford
students a greater opportunity to seek out careers in science and healthcare. Results of this program will add
to the understanding of effective science professional development experiences for teachers of diverse
learners.

Public health relevance
Project Narrative INMED: NEUROscience is a summer research experience for middle and high school teachers in American Indian tribal schools. This professional development program is focused on understanding the process of science and translating it into relevant science pedagogy. The program aims to build teachers' capacity to create engaging, and meaningful learning environments that excite, support, and instill confidence in American Indian students, in an effort to help them overcome some of the obstacles they face on the path to becoming STEM professionals.